Investigating the role of beta-1 integrin in regulating the adult satellite cell

DESCRIPTION (provided by applicant): The mammalian musculature provides mechanical force for locomotion. This system undergoes remodeling throughout lifetime and displays remarkable ability to regenerate from reservoirs of muscle stem cells, called satellite cells. Yet, how these cells are maintained, both in their quiescent state as well as in their regenerative capacity, is largely undefined. I propose to define the role of b1-integrin in these processes by using a Pax7-Cre-ERT2 fusion gene (the Pax7CE allele) for tamoxifen (tmx) inducible gene inactivation of a conditional allele of b1-integrin (b1-integrinflox), coupled with lineage tracingto address the questions outlined in the aims below: Aim 1: Function of b1-integrin in the quiescent satellite cell: I will examine b1- integrin inactivated satellite cells under normal homeostasis to assess: 1) Do quiescent satellite cells require b1-integrin? 2) Does the loss of b1-integrin affect adhesion of the satellite cell to the extracellular matrix? Aim 2: Function of b1-integrin in satelite cell activation: I will use injury models to further ask: 1) Can b1-integrin null satellite cells sstain muscle regeneration? 2) Do b1- integrin null satellite cells become activated and proliferate?

Public health relevance
PUBLIC HEALTH RELEVANCE: Developmental studies in the mouse have implicated b1-integrin as an essential regulator of muscle integrity. I plan to use newly developed genetic tools to define the role of b1-integrin in adult muscle satellite cells (i.e. muscle stem cells) in norma and injured conditions. My research will provide understanding towards the cellular biology of satellite cells, which have the therapeutic potential to ameliorate muscular dystrophies. __SpecificAimsTextDelimiter__ I. Specific Aims Skeletal muscles are contractile bio-machineries that effect locomotion. They are formed during successive waves of embryonic, fetal and perinatal myogenesis and possess tremendous capacity to regenerate throughout life via the use of resident stem cells called the satellite cells. To generate skeletal muscles, muscle stem and progenitor cells proliferate to expand the myogenic pool, differentiate into myocytes, and fuse to form multi-nucleated myofibers, units of the skeletal muscle. For structural support, myofibers utilize surrounding extracellular matrix (ECM) to cushion the contractile mechanical force and prevent damage. Attachment of myofibers to the ECM is mediated by members of the Integrin family of adhesion molecules. In particular, a7- and b1-integrins form a heterodimer on the myofiber surface to bind to the ECM component laminin. Mutations in a7-integrin and laminin a2 cause muscular dystrophy in humans, underscoring their structural importance. No mutation in b1-integrin has been associated with muscular dystrophy, presumably due to its requirement in early stages of embryogenesis (1). In addition to their expression in myofibers, b1- and a7-integrins are also expressed in and enriched at the basal surface of adult quiescent satellite cells. However, their function in adult satellite cells is not known. As the first step towards determining the role of integrins in satellite cell biology, I inactivated b1-integrin selectively in these cells and followed their fate by lineage tracing. My preliminary results suggest that b1- integrin is required for maintaining satellite cell quiescence as well as for regulating their activation upon injury (see preliminary results). To date, no other adhesion molecules have been shown to regulate niche occupancy and activation competency of satellite cells. I plan to investigate how b1-integrin regulates these two stem cell states. Aim 1. I will investigate the hypothesis that b1-integrin is required for proper anchoring of the quiescent satellite cell to its niche to prevent premature differentiation. Inactivation of b1-integrin in adult mouse satellite cells led to their reduction at the 3-week time point, accompanied by their incorporation into myofibers (Figure 2). I will examine how the loss of satellite cells may be associated with adhesive defects by examining the surrounding ECM components, and the apical/basal polarity and the cytoskeleton of satellite cells. I will then determine whether quiescent satellite cells spontaneously differentiate without proliferating upon the loss of b1-integrin. Imaging live b1-integrin null satellite cells on isolated single myofibers will allow for visualization of these events. Aim 2. I will utilize injury models to assess the activation capacity of b1-integrin null satellite cells. After b1-integrin inactivation, and prior to satellite cell number reduction, injury to the muscle resulted in a near absence of lineage-marked mutant cells and regenerated myofibers at 5- and 10-day time points post-injury (Figure 3). To explain this drastic phenotype, I hypothesize that b1-integrin null satellite cells are unable to proliferate, possibly due to a requirement for b1-integrin in satellite cell activation. Very little is understood regarding the process of satellite cell activation, for example it is unclear if activation and proliferation are concomitant steps in regeneration. I will address this issue by examining mutant satellite cells, from various times points post injury as well as in vitro, to determine if they can be activated and if they can proliferate. I will also outline approaches to determine the underlying mechanism causing regenerative dysfunction of satellite cells after removal of b1-integrin.